Administrative Core

ABSTRACT_Administrative Core
The Administrative Core will serve as a resource to the entire Impact of Antibody Effector Function Diversity
on Antiviral Activity in Situ P01 program, providing overall management, coordination and supervision of the
program. The overall director of the program, Georgia Tomaras will serve as the leader of the Administrative
Core, and experienced staff will be responsible for managing and coordinating the entire range of the PO1
activities, monitoring progress and ensuring that the overall goals of the program are implemented effectively
and efficiently. Specific Aims are the following:
AIM 1. Provide Scientific Oversight.
AIM 2. Provide Financial Oversight.
AIM 3. Provide data management and statistical support.
Through central management of all scientific, regulatory and financial activities of the program, the
Administrative Core directly interacts with each of the Projects and Cores. Similarly, each of the Projects and
Cores provide direct input to the Administrative Core through the participation of the Project and Core Leads
and key investigators as part of the Program’s Executive Committee. Collectively, the administrative group at
the Duke University has substantial expertise in the management of multi-institution grants and will ensure
success in management of the Impact of Antibody Effector Function Diversity on Antiviral Activity in Situ P01
program.